Sustaining evidence-based & performance-based practices in substance use disorder services

Project Summary Substance use disorder (SUD) is a chronic and relapsing illness that severely affects modern American society with insurmountable consequences. SUD is characterized by mental, physical, and behavioral imbalances that impair self-control and tolerance, leading to withdrawal and reduced quality of life. The direct economic impact of SUD on the United States healthcare system is more than $600 billion annually. Its indirect costs are also equally enormous with crime-related expenses, loss of productivity, and deteriorating society. More than 23 million Americans, nearly 10%, aged 12 years and older, are known to use some form of substances. However, about 90% of these patients do not receive therapy grounded in science resulting in a high rate of treatment failures, underscoring the existence of a divide between science and practice. Such a shortcoming in treatment practice is mostly because of the deficiency within the treatment system where the front-line therapists, having a lack of knowledge, fail to provide or inconsistently deliver evidence-based interventions (EBIs). To promote EBIs and address this daunting gap between science and practice, we propose a 1.5-day conference once a year in the next three years under the PA-18-648: NIH Support for Conferences and Scientific Meetings. The conference title is “Sustaining evidence-based & performance-based practices in substance-use-disorder services.” This conference will be led by the director of the Community Academic Partnership on Addiction (CAPA). The overarching goal of the meeting is to bring together all the stakeholders- -scientists, practitioners, primary healthcare providers, and students. The conference will facilitate listening, learning, familiarizing, and exchanging existing EBIs. The participants will have an opportunity to discuss successful implementation strategies for EBIs and how they can be sustained in SUD services. In line with these goals, the conference products will be designed to inform attendees about practical and tested implementation methods and sustainability in a variety of SUD and related health care services. The outcome of the conference and the products will help shape future policies, practices, health-service personnel training, and, more importantly, generate new collaborations between the participants. As a front-runner in SUD research and therapy with experience in organizing conferences, symposiums, and workshops, and having state-of-the-art facilities to conduct meetings, we have unique strengths to make this annual conference on EBIs in SUD a success. We intend to create a new platform for fruitful interaction among all SUD stakeholders and achieve sustained EBIs as the preferred method of treatment for SUD patients.

Public health relevance
PROJECT NARRATIVE Our team will organize a conference to promote efforts that will address the science-practice gap in substance use disorder services, a 1.5-day meeting each year in the next three years. The goal of this conference is to gather a wide array of stakeholders such as scientists, practitioners, primary healthcare providers, and students and make them aware of the effectiveness of sustained EBIs in SUD therapy. The conference and its products will be designed to inform attendees about the latest developments in EBIs and give them an opportunity to learn and discuss the current scientific strategies to successfully implementing and sustaining EBIs in usual SUD care services.